Muscarinic Receptors Regulate Colon Cancer Stem Cell Function and Invasiveness

In Veterans, cancers of the colon and rectum rank third in incidence behind those of the prostate and lung; about
one-third of Veterans diagnosed with colon cancer will die, primarily from metastatic disease. However, the
molecular events underlying the spread of colon cancer remain uncertain and current treatments for advanced
disease are limited and provide only transient benefit. More effective, durable treatments are urgently needed. With
previous VA Merit support, we found M3 muscarinic receptor (M3R) activation promotes colon cancer progression
by many adverse actions. Our new findings reveal that two muscarinic receptor subtypes, M1R and M3R encoded
by CHRM1 and CHRM3, are overexpressed early in the colon cancer continuum and in colon cancer stem cells
(CCSCs) which drive tumor resilience, relapse, and metastasis. These findings suggest concurrently targeting M1R
and M3R directly may have great translational potential. Accordingly, we propose to test the central hypothesis that
selectively targeting muscarinic receptor subtypes attenuates colon cancer progression and resistance to therapy.
To do so, we must fill key gaps in knowledge regarding how M1R and M3R expression is regulated in colon
neoplasia and identify the individual roles of M1R and M3R in driving cancer progression. Our new data reveal that
as neoplasia progresses, M1R expression is progressively reduced compared to M3R expression; in most colon
cancers M3R levels greatly exceed those of M1R and we could not detect M1R in CCSCs at the tumor invasive
edge. Notably, we identified a reciprocal relationship between M1R expression and that of two microRNAs, miR-
107 and miR-103, predicted by computational analysis to interact with the CHRM1 3’-UTR. These findings are
consistent with miR-107/-103 suppressing CHRM1 mRNA translation in advanced cancer, thereby damping M1R
levels. As miR-107/-103 can also amplify β-catenin signaling, which targets CHRM3, these miRNAs may indirectly
augment M3R levels. Increased levels of M3R may also result from reduced expression of miR-30-5p which can
interact with the CHRM3 3’-UTR and has an inverse relationship with M3R levels in colon cancer. Intriguingly, our
new findings also show colon cancers also express a circular (circ)RNA, cTFRC, capable of ‘sponging’ miR-107 / -
103; and, thus indirectly regulating M1R and M3R levels by reducing levels of free miR-107 and miR-103 – we
propose to leverage the therapeutic potential of circRNAs. Building on these new findings, we propose to use
sophisticated in vitro, ex vivo, and in vivo models to perform a meticulous, focused investigation of the post-
transcriptional regulation of M1R and M3R expression by these non-coding RNAs and learn how modulating M1R
and M3R levels impacts important preclinical endpoints – tumor growth, spread, response to chemo- and
immunotherapy, and animal survival. To accomplish these goals, we propose two comprehensive Specific Aims:
Aim 1: Rigorously test the effects of selectively depleting and inactivating M1R and M3R on colon cancer
progression, responses to chemo- and immunotherapy, and survival.
Aim 2: Define the exact roles of miR-107, -103, and -30-5p as regulators of M1R and M3R levels and
biomarkers for colon cancer progression, and the therapeutic potential of circRNA sponges.
As muscarinic receptors are selectively druggable by inhibitors already FDA-approved for other indications, we
believe demonstrating the therapeutic benefits of modulating muscarinic receptor activity in animal models that
mimic human disease will spur clinical trials of such agents repurposed to treat colon cancer. Identifying a novel
microRNA/circRNA/muscarinic receptor axis linked to colon cancer progression will be a major conceptual advance
whose therapeutic promise is exemplified by our newly proposed circRNA sponges for miR-107/-103.

Public health relevance
This VA Merit application focuses on defining how the balance between two muscarinic receptor subtypes, M1R and M3R, governs the function of colon cancer stem cells, the ‘mother cells’ from which other colon cancer cells arise – colon cancer stem cells drive tumor spread and resistance to treatment. We will learn how the expression of M1R and M3R in colon cancer is regulated. Then, we will see how blocking these receptors selectively affects responses to chemotherapy and survival in human colon cancer cells, 3-dimensional organoids (tumoroids), and in an innovative animal model that mimics colon cancer progression in people. We believe the work proposed will advance our long-term goal of developing new, effective and safe treatments for invasive colon cancer, a disease with limited treatment options that comprises 10% of all cancers in U.S. Veterans.